Mentorship in Investigating Novel Risk Models and Prognostic Factors in Patients Less Than 21 Years Old with Venous Thromboembolism

ABSTRACT
Venous thromboembolism (VTE), consisting of deep vein thrombosis (DVT) and pulmonary embolism (PE),
affects approximately 1 in 200 hospitalized patients <21 years old, and annual health care costs of pediatric VTE
can be estimated at $72M in the U.S. alone. As in adults, PE can be fatal in pediatric patients, and DVT can
result in long-term chronic venous insufficiency (the post-thrombotic syndrome [PTS]). However, treatment and
prevention of VTE with anticoagulant medications carries a risk for bleeding, which can be life-threating. In order
to optimize net clinical benefit, pediatric subpopulation-specific risks assessment models (RAMs) must be
developed and validated, and prognostic factors identified, in patients <21 years old. This has been the focus of
my career-long research work and mentorship. Recently, my multinational collaborators and I have made
significant advances in pediatric VTE treatment via publication in JAMA of practice-changing findings from the
U01-funded Kids-DOTT randomized trial on duration of anticoagulation for acute VTE in patients < 21 years old,
and have also generated published evidence on several subpopulation-specific RAMs over the past 3 years.
Yet, critical knowledge gaps remain regarding RAM development in critically ill patients and the investigation of
prognostic markers for clinically-important VTE outcomes, including recurrent VTE and PTS. In this K24
proposal, I will mentor six junior faculty clinical/translational researchers focused in VTE prevention and
treatment, from across four pediatric disciplines (hematology, critical care medicine, hospital medicine,
pharmacy) and three academic institutions (Johns Hopkins University [JHU], University of Alabama at
Birmingham, Harvard University), including three females and three individuals of color or historically
underrepresented backgrounds. The proposed studies build upon existing collaborations in data science and
biomarker-informed prognostic modeling, and will leverage data and/or biospecimens from multicenter studies
in which I play a leadership or senior collaborating role. In each project, the junior faculty mentee will also have
direct interaction with new or existing patients on study, for de novo data collection. Under this K24 proposal, I
will enhance my mentorship expertise via the JHU Master Mentor Program and grow my knowledge in both
Bayesian methods and plasma proteomics through online coursework and regular interactions with experts in
these fields, who also serve as co-investigators in the proposed projects. By facilitating the expansion of my
interdisciplinary research in pediatric VTE and strengthening my abilities to successfully mentor future junior
faculty clinical and translational researchers in the field of pediatric VTE from across a range of disciplines and
institutions, the proposed K24 will have significant impact as a force-multiplier in the pediatric VTE field.

Public health relevance
NARRATIVE This K24 proposal addresses a critical public health need to improve treatment and prevention of pediatric venous thromboembolism (VTE), a condition that affects 1 in 200 hospitalized children. The six mentored projects will generate foundational evidence toward achieving this goal, by developing new pediatric subpopulation-specific risk assessment models and elucidating novel prognostic factors in pediatric VTE, leveraging (and collecting new patient-derived data within) recently-completed or ongoing multicenter studies in which the mentor plays a leadership role. This K24 proposal will also expand the skillsets of the mentor via the Master Mentor Program of the Johns Hopkins Institute for Clinical and Translational Research, as well as through distance learning-enabled coursework in both Bayesian methods and proteomics through Johns Hopkins University and other expert institutions/organizations, enhanced by direct interactions with internationally- recognized experts in these fields who also serve as co-investigators in the mentored projects.